Regulation of Ceramide Synthase by Protein-Protein Interaction

Title and the Abstract of the Parent Grant
Title: REGULATION OF CERAMIDE SYNTHASE BY PROTEIN-PROTEIN INTERACTION
Abstract:
Ceramides form the backbone of all sphingolipids, and ceramide synthases (CerS) are critical enzymes
for de novo production of ceramides. In spite of the key role of CerS in ceramide generation, there is a serious
deficiency in understanding how these enzymes are regulated. The long-term goal of this project is to uncover
and understand the fundamental molecular mechanisms of how CerS enzymes are regulated. Using a
proteomics approach, we discovered that the small heat shock protein Hsp27 interacts specifically with CerS1.
Based on our preliminary data we generated the novel hypothesis that Hsp27 is a negative regulator of CerS1
activity via direct interaction that can be modulated by p38-MK2 MAPK mediated phosphorylation of Hsp27, and
that down-regulation of Hsp27 induces CerS1/C18:0-ceramide mediated cellular responses. To test this
hypothesis, we propose the following Specific Aims: Aim 1: Define the biochemical significance of Hsp27
mediated CerS1 regulation in cells with respect to sphingolipid metabolism and signal transduction. Aim 2: Define
the biological significance of Hsp27 mediated CerS1 regulation. Aim 3: Determine the mechanism of Hsp27-
CerS1 protein-protein interaction. Overall, these studies will establish Hsp27 as an endogenous modulator of
CerS1 and uncover a novel mechanism of how Hsp27 regulates CerS1 and CerS1/C18:0-ceramide governed
mitophagy and cancer cell death. The knowledge generated from this study will help design mechanism-based
novel therapies against cancer and other pathologies in which C18:0-ceramide is the key mediator by identifying
new methods to modulate CerS1 activity.

Public health relevance
Narrative of the Parent Grant The bioactive lipid, ceramide has very important roles in many pathological contexts including cancer and diabetes. Ceramide synthase (CerS) enzymes are crucial for ceramide production, however the basic molecular mechanisms of their regulation is largely unknown. The goal of this proposal is to establish and understand the molecular mechanisms of CerS1 regulation by Hsp27, and therefore will provide the knowledge for designing innovative therapies against cancer and other pathologies in which ceramide is implicated by identifying new methods to modulate CerS1 activity.